Core B: Biostatistics and Data Management

PROJECT SUMMARY/ABSTRACT
This Core provides centralized services to the Program Project in four related areas: biostatistics, research
computing, data collection, and data management. The biostatisticians collaborate in all phases of research
from study design, through interim analysis and monitoring, to final analysis and manuscript
preparation. Biostatisticians were co-authors on a breadth of manuscripts funded by this Program Project
during the previous funding period and are integral parts of the protocol development and review process. The
computing group is responsible for the maintenance and operation of shared computing systems. These
include a cluster of Itanium machines that support a centralized patient database, known as Gateway. The
computing staff will create and maintain entry and reporting programs for Gateway, assist others in data
extraction from the database, and maintain electronic connections to laboratory information which is
downloaded directly to Gateway. The data collection group is responsible for data abstraction and entry into
Gateway, and for maintenance of archival research files, which are stored in a web-accessible optical image
library (OWL). The staff follow an explicit protocol for data abstraction, coding, key entry, and quality control
that is applied uniformly to all recipients entering research protocols within the Clinical Research Division,
including protocols supported by this program project.

Public health relevance
PROJECT NARRATIVE The activities of this Core involve collaboration with each Project and each Core in the design and biostatistical analysis of all studies support by this Program Project, including observational studies, pre-clinical studies, laboratory studies, and clinical trials. The Core also supports the collection of data from patients enrolled in the associated clinical trial, and makes these data and data required for observational studies available in a relational database.